A comparison of environmental and genetic risks for schizophrenia and bipolar disorder: A Swedish national study

Abstract
In this study we seek to understand how environmental factors influence the risk of developing
schizophrenia (SZ) and bipolar disorder (BD) and how these risk factors interact with genetic risk for these
disorders. SZ and BD are of major public health importance owing to their profound personal and societal
costs. Major advances have been made in understanding the genetic architectures and specific loci
conferring risk for these disorders individually and jointly. While robust, replicated findings for environmental
risk factors for SZ have been identified, these have failed to materialize for BD. We intend to address to
address this imbalance through parallel investigations of environmental risk for SZ and BD and explore
possible interactions with genetic risk for these disorders.
For this work, we will utilize data from the Swedish National Registers which contain data across the
lifespan for the Swedish population (>10 million). Our first aim seeks to assess the impact of environmental
risk factors on the development of SZ or BD and whether these are shared or divergent. These will include:
urban living, infections, obstetric complications, migration, childhood adversity, cannabis use, and winter or
spring birth.
Additionally, an individual’s genes may differentially affect sensitivity to environmental exposures.
Therefore, we will use both indirect (family history) and direct (molecular genetic) assessments of genetic
risk for SZ and BD in relation to environmental exposures. Registry information available for this study is
accurate and complete out to third degree relatives for total population measures of family history for these
disorders (Aim 2). Existing molecular genetic data collected in Sweden for 10,059 SZ cases, 11,052 BD
cases, and 22,138 controls will be used for analyses of directly measured genetic risk (Aim 3).
Concurrent examination of BD and SZ will allow for direct comparisons of how environmental exposures act
independently and in conjunction with genetic risk to shape these diagnoses. Elucidating the mechanisms
which give rise to these related conditions may reveal opportunities for prevention efforts and therapeutic
targets to ultimately reduce the personal and societal burdens of these devastating disorders.

Public health relevance
Project Narrative The personal, familial, and societal costs of schizophrenia and bipolar disorder are enormous. This study will use Swedish population-level data across the lifespan to explore shared and divergent environmental risk factors for schizophrenia and bipolar disorder and their relationships to inherited risk factors - both familial risk and molecular genetic risk. Through these studies, we will derive a more comprehensive understanding of the influences leading to schizophrenia and bipolar disorder diagnoses which will lead to new opportunities for prevention tactics and treatment options.